Infectious Diseases Training Program

Project Summary
Objectives: The Infectious Diseases Training Program at the University of Virginia aims to develop predoctoral
graduate students and physician fellows into investigators who will be leaders in the field of infectious diseases.
Side-by-side interdisciplinary training of predoctoral and physician postdoctoral fellows is the central feature.
Rationale: Basic and clinical scientists bring unique and complementary perspectives to infectious diseases
research. Dual training catalyzes innovative approaches and solutions, now and throughout trainee careers.
Key activities: The Program features the Tuesday “Infectious Diseases Research in Progress,” Wednesday
Translational Journal Club, and weeklong Short Course in Clinical Microbiology. All pair a physician fellow and
a graduate student to drive collaborative, synergistic training in infectious diseases research. There is a biweekly
seminar series with outside speakers. Annual activities include the Research Day, Mentor-Mentee Retreat, and
360° review by trainees and faculty. An External Advisory Board meets every 2-3 years.
Institutional support: 1st year predoctoral stipends, tuition remission, pre- and postdoc stipend supplementation,
seminar program costs, gap funding for faculty and trainees, 10% effort for MPIs, administrative assistant.
Projected number of trainees: 5 predoctoral and 5 physician postdoctoral trainees (no change).
Mentors: The Program has 18 faculty (50% women; 17% URM) from 5 Departments. All are NIH supported as
PIs through 2021, and 16/18 through 2023, with average of $1,032,250/mentor in current year direct costs.
Faculty are postdoc mentors (13/18, median 5 trained), predoc mentors (11/18, median 4 trained), and junior
mentors (assigned co-mentors - 4/18; mean 1 trained).
Predocs: 89% graduated with PhD (17/19) last 10 years, and 100% (8/8) last 5 years; time to degree 5.5 years.
The graduated predoc trainees of our current mentors had mean/median 1st author publications 2.5/2.0; for all
publications 3.9/3.0. 93% (42/45) of graduates are currently in research (19/45), research-related (11/45) or
further training (12/45).
Postdocs: 100% (48/48) completed two years of research training; 69% (33/48) of graduates are primary
research (19/48), research-related (13/48) or further training (1/48); 65% (31/48) are Assistant or Associate
Professors. The graduated postdoctoral trainees of our current mentors have mean/median for 1st author
publications of 2.9/3.0, and total publications averaged 4.4/4.5/fellow. 10/48 have received NIH K grants.
URM: 23% (7/30) of all trainees in the last 4 years, 6/16 predocs and 1/14 postdocs.
Applicant Pool: For 2019-2020 there were 39 new predoctoral entrants eligible for support by the 3 open predoc
positions; the 3 new appointees had an average of 9 months of prior research experience and mean GPA of 3.3.
There were 41 eligible postdoc applicants for the 3 open postdoc positions. The 3 new appointees had on
average 3.3 and 1.3 total and first author papers.

Public health relevance
Narrative The SARS-CoV-2 pandemic underscores the paramount threat that infectious diseases are to public health in the 21st century. The Infectious Diseases Training Program prepares predoctoral and physician-scientist fellows to investigate and respond to microbes that are new and ongoing threats to human health.